Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MAITC): Clinical Translation and Validation Core

PROJECT SUMMARY: Clinical Translation & Validation Core
The activities of the Clinical Translation and Validation Core will support the pilot project research process for
the Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MAITC)
by providing access to state-of-art facilities, consulting services, and intellectual resources to enable validation
and feasibility-testing of AI-enhanced technologies.
To achieve these objectives, the Clinical Translation and Validation Core will pursue the following three aims.
First, it will provide a streamlined validation pipeline for taking promising AI-enhanced technologies from
benchtop to real-world deployment to enable at-home use for older adults and patients with AD/ADRD. To
accomplish this, the Clinical Translation and Validation Core will leverage state-of-art facilities for technology
validation at the UMass Amherst Institute of Applied Life Sciences (IALS) and the Northeastern Consortium on
Technology for Proactive Care. The Clinical Translation and Validation Core will also provide pilot project
teams the opportunity to recruit participants in both urban and rural settings across Eastern and Western
Massachusetts. The Clinical Translation and Validation Core will leverage longitudinal study cohorts already
engaged with the Massachusetts Alzheimer’s Disease Research Center (MADRC) and the Harvard Brain
Study (HABS), and ad-hoc cohorts at the Brandeis and Brigham Women’s Hospital Roybal Centers and
UMass IALS. Second, the Clinical Translation and Validation Core will support the pilot project process by
contributing to defining the call for proposals by suggesting AI-enhanced technologies that are suitable for
validation by leveraging MIATC resources (in coordination with the Technology Identification and Training
Core). It will also provide input regarding the selection of pilots based on technical, usability, and feasibility
criteria and offer consulting services and technical support to enhance likelihood of pilot project success. Third,
the Clinical Translation and Validation Core will maintain a continually evolving knowledge base of emerging
advances in AI-enhanced technologies that have the potential to significantly improve Healthy Aging and
AD/ADRD care. This database will summarize the key strengths and weaknesses of these technologies and
the types of settings where each technology could be used. The Clinical Translation and Validation Core will
also facilitate pairing of technology developers with clinical researchers and other stakeholders with interest in
validating AI-enhanced technologies. The activities of the Clinical Translation and Validation Core will increase
the impact of the pilot project program by providing teams with resources to bridge the gap between research
and implementation in real-world settings.